Enhancing the Community-Academic Aging Research Network to Support Assistive Technology (AT) Research for Older Adults by Designing for Dissemination and Health Equity

Project Summary/Abstract
Assistive technology (AT) has the potential to improve the health and function of older adults. However, multiple
barriers, such as perceived stigma, financial costs, and perceived threats to privacy, impact older adult
acceptance and use of AT. Studies identify that older adults from historically underrepresented (HU) groups have
less access to and use of AT. In addition, older adults particularly those from HU groups, are often excluded from
participating in research and in AT development. Further, AT development occurs in silos with little, if any, input
from older adults and other disciplines (clinicians, social scientists, healthcare providers), thus limiting innovation
and new ways of thinking about AT use and the needs of older adults. Our long-term goal is to increase the
number and reach of effective AT interventions designed to improve the health and function of older adults,
increase aging in place, and reduce disparities. The objective of this proposal is to create a mature and
sustainable infrastructure that facilitates the formation and collaboration of transdisciplinary teams of engineers
and computer scientists, healthcare providers, social scientists, and community partners to develop, test, and
disseminate innovative AT interventions for older adults from diverse and historically underrepresented
populations with age-related or multiple chronic conditions. To achieve this goal, we will expand the Community-
Academic Aging Research Network (CAARN) infrastructure in a new direction to facilitate older adult
engagement in AT and to connect engineers and computer scientists, healthcare providers, and end users to
promote a better understanding of the technology needs of a diverse older adult population and create an
environment for transdisciplinary engagement. We will accomplish our objective through three aims: Aim 1: To
bring together multidisciplinary researchers (engineers, computer scientists,, clinicians, social scientists) and
community end users to investigate the needs for and barriers to using AT from historically underrepresented
communities prior to design; Aim 2: To facilitate community-academia partnerships to develop new or refine
existing AT through iterative cycles of input/design/prototype testing and feedback; and Aim 3: To demonstrate
preliminary feasibility, acceptability, safety, and functionality of new and/or refined AT among adopters,
implementers, and end users of the technology. The result of this new infrastructure will be the development of
new AT that: a) is feasible to use with broad reach and adoption; and b) is likely to be effective in promoting
equitable older adult independence and health.

Public health relevance
Project Narrative This proposal will expand the infrastructure of the Community-Academic Aging Research Network (CAARN) in a new direction to promote the formation of innovative transdisciplinary teams including engineers and computer scientists, clinicians, healthcare providers, social scientists, and historically underrepresented older adults to facilitate the development, testing and dissemination of new or refined assistive technology to improve the health and function of older adults and reduce disparities.